Prediction and Word Learning in Young Children with Autism Spectrum Disorder

Project Summary/Abstract:
Not required for this Administrative Supplement

Public health relevance
Project Narrative: Not required for this Administrative Supplement